Training in Musculoskeletal Research

DESCRIPTION (provided by applicant): The purpose and objectives of the training grant program proposed for continued support are to prepare bioengineers for an academic career in orthopaedic research as part of a focused program leading to the Ph.D. Degree in Bioengineering. Training bioengineers in the same laboratory, side-by-side with orthopaedic surgeons and life scientists at various levels of training, will continue to foster an environment conducive to multidisciplinary research and education in the orthopaedic arena. Indeed, this has been the formula that we have found very successful in our training program thus far. In today's complex and interdisciplinary research world, this approach is more essential than ever. Trainee research areas represent a wide range of musculoskeletal problems including, but not limited to, the cellular and molecular biology of bone growth, repair, ossification, and maintenance~ the etiology and pathogenesis of tendon and ligament injury, repair, and regeneration~ mechanical loading effects on articular cartilage~ and nanofibrous scaffolds for meniscus repair and development. In addition to formal didactic coursework, training opportunities include seminar series, journal clubs, and other enrichment activities. The primary participating departments in this training program are the Department of Orthopaedic Surgery in the Perelman School of Medicine and the Department of Bioengineering in the School of Engineering and Applied Science at the University of Pennsylvania. Both departments have grown significantly over the past five years. Five predoctoral trainees are requested in this continuation grant. It should be noted that the predoctoral trainees work in a structured, yet flexible environment while completing course requirements toward the Ph.D. Degree in Bioengineering. Despite the fact that the PhD program is typically five years in total duration, typically, only two years, and not the first year, will be supported by this training grat so that positions can be made available for new trainees to grow the program. There are two primary training sites for this training grant. The first primary site is the McKay Orthopaedic Research Laboratory in Stemmler Hall in the Department of Orthopaedic Surgery and the second is the orthopaedic research unit in Skirkanich Hall in the Department of Bioengineering. These two facilities represent >90% of the dedicated training space for the program. Finally, it should be noted that the University of Pennsylvania operates a large number of state-of-the-art, sophisticated core facilities that are available to faculty and trainees. Relevance: Musculoskeletal problems are extremely common with a high cost to society requiring substantial research and training efforts. This program will train orthopaedic bioengineers in fundamental research in order to position them for high-level academic careers, in which they will investigate important musculoskeletal problems and train the next generation of researchers.

Public health relevance
PUBLIC HEALTH RELEVANCE: The purpose and objectives of the training grant program proposed for continued support are to prepare bioengineers for an academic career in orthopaedic research as part of a focused program leading to the Ph.D. Degree in Bioengineering. Training bioengineers in the same laboratory, side-by-side with orthopaedic surgeons and life scientists at various levels of training, will continue to foster an environment conducive to multidisciplinary research and education in the orthopaedic arena. Indeed, this has been the formula that we have found very successful in our training program thus far and, in today's complex and interdisciplinary research world, this approach is more essential than ever.